Adjuvant, mimicry and booster requirements for shepherding the development of neutralizing antibodies to the high-mannose patch on HIV-1

PROJECT SUMMARY
The HIV-1 envelope spike (Env) bears a cluster of oligomannose-type glycans that is a target for broadly
neutralizing antibodies (bnAbs). However, while nAbs to this cluster, dubbed the high-mannose patch
(HMP), are known to develop in at least some HIV-infected individuals, past attempts to elicit similar
antibodies by immunization have been largely unsuccessful. Most previous approaches have involved
presenting clusters of natural or synthetic high-mannose glycans on the surface of carrier proteins. The
difficulty in eliciting high-mannose-targeting nAbs by immunization is believed to relate, at least in part,
to the ‘self’ nature of the targeted glycans; naïve B cells bearing Ig receptors of the desired fine specificity
or affinity might be anergic or at relatively low frequency due to tolerance mechanisms.
The approach that we are pursuing is based on the scientific premise that antigenic mimicry of
mammalian host structures can stimulate cross-reactive antibodies if such mimics are presented in the
proper ‘foreign’ milieu. Our overarching hypothesis is that, upon immunization, an antigenic mimic of
mammalian oligomannose will more readily elicit antibodies that bind the HMP than native or synthetic
oligomannose. In our progress report, we show that a CRM197-conjugate of our lead oligomannose
mimetic, the design of which is inspired by a bacterial polysaccharide with resemblance to mammalian
oligomannose, is bound with high avidity by various HMP-specific bnAbs as well as their germline
precursors. Furthermore, human antibody transgenic mice immunized with this neoglycoconjugate yield
antibodies that bind recombinant HIV-1 SOSIP trimers, albeit only when the conjugate is formulated in
the TLR4-stimulating Th1-adjuvant GLA-SE; not when formulated in Th2- or mixed Th1/2-adjuvants.
Based on our findings so far, we propose in this renewal application to extend our investigations. A first
step (Aim 1) will be to probe the relevance of Th1 stimulation further, by assessing immunogenicity of
our lead glycoconjugate when formulated with other Th1-directing adjuvants. These additional adjuvants
will not be agonistic for TLR4, thus helping to reveal whether stimulating TLR4 is relevant. We will assess
also (Aim 2) the significance of antigenic mimicry for triggering high mannose-specific antibodies, by
comparing the immunogenicity of our lead mimetic to synthetic oligomannose. We will evaluate also
whether incorporating an archetypical component of gram-negative bacterial LPS –Kdo and lipid A—into
our lead glycoside is immunologically beneficial. Our third step (Aim 3) will be to investigate whether
injecting glycoconjugate-primed transgenic mice at specific time points with select SOSIP trimers boosts
nAb titers. We expect our findings to help sharpen our strategy and critically inform the pursuit of future
preclinical studies. Results from this research could inform other HIV vaccine design strategies also.

Public health relevance
PROJECT NARRATIVE One of the major challenges in the HIV vaccine field continues to be the development of one or more formulations that can elicit antibodies to conserved sites on the spike protein. Our interest is in a reasonably conserved cluster of sugar molecules on the HIV spike. Antibodies to these sugar molecules are not elicited readily by conventional approaches, possibly because these sugars are imparted by the cell and therefore considered ‘self’ molecules. We are investigating whether synthetic sugars molecules resembling the target sugars can ‘trick’ the immune system into producing antibodies that will bind the similar-looking sugar molecules on the HIV spike surface. In this renewal application, we propose to continue our investigations on this front. In the short term, we expect our findings to provide insight into immunological discrimination between self- and non-self-sugar molecules and how the application of adjuvants might promote such recognition/differentiation.